Administrative Core

PROJECT SUMMARY/ABSTRACT – CORE A
The HCC OvCa SPORE Administrative Core (Core A) is co-directed by SPORE PIs Ronald Buckanovich, MD,
PhD and Robert Edwards, MD. Core A will (i) provide scientific, fiscal, and general administrative oversight to
all SPORE components, (ii) work to facilitate the research productivity of the three SPORE Projects, (iii)
expand the utility and efficiency of the SPORE’s two Shared Resource Cores, and (iv) ensure the success of
the Career Enhancement Program (CEP) and Developmental Research Program (DRP) to generate a pipeline
of new OvCa investigators and projects. To ensure the success of the SPORE, Core A will coordinate sharing
of SPORE data as well as internal and external communications and interactions. This includes coordinating
agreements with collaborating institutions and community outreach with patient advocates. Core A will convene
monthly meetings attended by all SPORE Investigators, coordinate periodic administrative and scientific
reviews, release and publicize RFAs and arrange for the review of received CEP and DRP applications, and
work closely with the NCI Translational Research Program Office. It will provide the administrative framework
through which the SPORE Executive Committee, Internal Advisory Board (IAB), and External Advisory Board
(EAB) can evaluate program activities and will redirect resources, as appropriate, to maximize progress toward
the SPORE’s translational goals. Core A will monitor the budgets of the individual SPORE, CEP, and DRP
Projects and Cores to ensure that no duplication of effort occurs between the SPORE and institutional shared
resources, national consortia or cooperative groups, or other funded research grants. The Core will also
ensure that the SPORE’s research activities are conducted in compliance with all local and federal regulations
and guidelines, including those for protecting the safety and personal health information of patients. Core A will
benefit from the effort of a qualified SPORE Administrator who assists in scheduling and in preparing reports
and manuscripts.
Impact: Through Core A functions, the SPORE as a whole will benefit from the centralization of essential
services, and each SPORE component will be afforded the opportunity to maximize the effort devoted to
research and patient-oriented advances in ovarian cancer.